ACTIVITY OF PMPA PRODRUG IN HIV INFECTED PATIENTS

The objective of this proposed study are to (a) elevate the safety of single and multiple doses of PMPA Prodrug when administered orally to HIV-infected subjects (b) to evaluate the pharmacokinetics of single and multiple doses of PMPA Prodrug as demonstrated by effects on CD4 count and HIV RNA.